Studying roles of CASP8 SVA GGGAGA repeat expansions in Alzheimer's disease

Project summary
Alzheimer’s disease (AD), the most common form of dementia, is characterized by cognitive decline and
impairment of behavioral and functional abilities. Approximate 6.7 million people in the United States are affected
by AD and this number is anticipated to triple by 2060. While mutations in amyloid precursor protein (APP) and
presenillin (PSEN1 and PSEN2) are known to cause familial early onset AD and the APOE4 variant is a common
disease risk factor, the genetic contributions to the majority of late onset AD cases are not clear. While the
accumulation of Aβ plaques and hyperphosphorylated tau (pTau) are the hallmark features of AD, it is not clear
if targeting Aβ plaques or pTau is an effective treatment strategy for sporadic AD. Our recent findings strongly
support the contribution of microsatellite repeat expansions in AD. Using antibodies targeting polymeric proteins
reported in known repeat expansion disorders, we show poly-glycine-arginine (polyGR+) aggregates are
frequently found in AD brains with unknown genetic etiologies. Using a repeat expansion pulldown tool, we
identified a novel polyGR-encoding GGGAGA repeat expansion in CASP8 (CASP8-GGGAGAEXP). The CASP8-
GGGAGAEXP produces polyGR-containing proteins in CASP8-GGGAGAEXP(+) AD brains and in transfected cells.
A rare, specific variant of this expansion, CASP8ADR1 containing stretches of (GGGAGA)4CG motifs is
associated with increased AD risk in three independent cohorts (odds ratio = 2.2, p<0.0001). We also show
CASP8ADR1 produces higher levels of rGGGAGAEXP RNA inclusion and polyGR aggregates, and is more toxic
than the common CASP8-GGGAGAEXP variant in cells. Our finding is exciting because it connects AD to a large
family of >70 rare neurological disorders caused by repeat expansion mutations including C9orf72
frontotemporal dementia (FTD) (C9-FTD). Molecular mechanisms of these diseases involve protein loss- or gain-
of-function (GOF), RNA GOF, and the toxicity of polymeric proteins produced by repeat-associated non-AUG
(RAN) translation. PolyGR proteins have been shown to be highly toxic in C9 FTD models. In AD autopsy brains,
polyGR+ aggregates are increased with AD pathological hallmarks (e.g. increased pTau in the hippocampus and
increased Aβ plaque and pTau deposition). Interestingly, polyGR+ aggregate levels are increased in AD cases
that experience brain injuries and high blood pressure that have been shown to induce oxidative stress. We
hypothesize that CASP8ADR1 contributes to AD by producing toxic RAN proteins and oxidative stress increases
AD risk in CASP8ADR1 carriers by increasing the accumulation of RAN protein aggregates. We will test this
hypothesis in three specific aims: Aim 1) To test the hypothesis that expansion RNAs and polyGR-containing
proteins expressed from CASP8ADR1 accumulate in regions with AD pathology in CASP8ADR1(+) AD autopsy
brains; Aim 2) To test the hypothesis that CASP8ADR1 alleles produce repeat expansion products that are
associated with molecular hallmarks of AD in patient derived organoids; and Aim 3) To test the hypothesis that
removing or blocking expression of the CASP8ADR1 will mitigate disease phenotypes in patient derived models.

Public health relevance
Project narrative Alzheimer’s disease (AD) currently affects approximate 6.7 million people in the United States, however no effective treatments are available due to our lack of understanding of disease mechanisms. This proposal will study the contribution of a novel GGGAGA repeat expansion variant in CASP8 that we have recently identified to be associated with increased AD risk. Understanding the molecular mechanisms that the AD-risk CASP8 GGGAGA repeat expansion variant contributes to AD will provide novel insight into AD pathogenesis and accelerate therapeutic development.